Region 7 Admin-Core

Administrative Core
Abstract
The University of Massachusetts (UMMS) is uniquely qualified to serve as Region 7 of the
Network of the National Library of Medicine. Building on previous strategies and past
performance, UMMS will develop, expand, and support a regional and national Network
Membership. UMMS leadership has the expertise to manage and administer day to day
operations especially as it relates to growing new members, engaging collaborators, developing
an advisory structure, soliciting feedback, and identifying and responding to the needs of
network members and the populations they serve. UMMS will assist Network members in
utilizing NLM’s products and services and carry out strategies in order to promote them to
create and support education and outreach programs designed to increase health professionals,
librarians, the public health workforce, and consumer’s awareness of and access to NLM and
NNLM resources. UMMS will coordinate the activities of the region with other regions and within
the national program and serve as a contact point for the region in relation to other library and
information networks, health organizations, and professional associations.

Public health relevance
Administrative Core Project Narrative Working in collaboration with NNLM staff, Network Members, and community based- organizations, Region 7 will work to improve health literacy and access to reliable health information so that individuals have the capacity to obtain, process, and understand basic health information needed to make appropriate health decisions. This will be done by promoting the products and services of the National Library of Medicine.